HSR&D Research Career Scientist Award Application

Dr. Humphreys is a Senior Research Career Scientist who conducts health services research in
the area of substance use disorder and its related comorbidities (e.g., depression, PTSD). These prevalent
disorders contribute to substantial morbidity and mortality in the Veteran population.
The substance use disorder interventions Dr. Humphreys studies are broad, ranging from
professionally-operated and delivered treatment programs, mutual help groups operated by peers, and
Internet-delivered treatments that are largely self-administered. His work has addressed all aspects of
these different types of intervention, including their accessibility, outcomes, costs and mechanisms of
action.
Dr. Humphreys has also pursued a line of research focused on the system and policy
environment of mental health services. This work has comprised studies of how VA care managers make
policy decisions, how funding and legislation shapes services in the VA and outside of it, and how staffing
patterns and practices influence the nature of mental health care.
In addition to these substantive foci, Dr. Humphreys has contributed to improving health services
research methods. This includes developing and validating measures of phenomenon in the field (e.g.,
health care staff beliefs about addiction, mutual help group involvement) that have since become widely-
used. It also comprises adapting well-established statistical methods from other fields (e.g., cluster
analysis, instrumental variables modelling) to the central questions of mental health services research.
A particularly influential aspect of Dr. Humphreys' methodological work focuses on the
demographic and clinical representativeness of clinical trial samples and how such samples differ from
patients seen in everyday practice. This work comprises original empirical studies as well as integrative
literature reviews. This scientific program addresses clinical translation questions (e.g., is it safe to
generalize from an unrepresentative sample?) as well as ethical issues (e.g., Does trial sample
unrepresentativeness have a disparate impact on women and people of color?). This research program
has generated significant international interest, inspiring replications in other countries in addition to
sparking interest within VA nationally.
Dr. Humphreys has also put extensive effort into translating all of the above research findings
into policies that improve health care for Veterans and for the nation as a whole. This has included serving
on Secretarial and Under Secretarial VA initiatives focused on care improvement, helping craft the U.S.
Surgeon General's first report on addiction, and advising state and local officials on how to better tackle
addiction. Dr. Humphreys' research has been presented to Congressional Committees by national VA
leadership on many occasions, and has also been employed extensively within VA Central Office to make
consequential decisions about the shape of VA mental health services nationally.

Public health relevance
Keith Humphreys, Ph.D. is a Senior Research Career Scientist in the VA who researches substance use disorders and their treatment. This research focus is important because the use of nicotine, alcohol, cocaine, heroin and other psychoactive drugs takes an enormous toll on the health of Veterans and imposes substantial cost on the Veterans Health Administration. Dr. Humphreys is studying how to make treatments for substance use disorders and related conditions (e.g., psychiatric problems, infectious diseases) more accessible to and effective for Veterans. This includes studies of Internet-delivered treatments, self-help groups operated by peers and health care policies that support better treatment. Dr. Humphreys is also actively involved as a mentor to young investigators who intend to pursue VA careers as scientists studying addiction and other mental health problems.